Air pollution, biomarkers of exposure, and lung function in vulnerable populations

PROJECT SUMMARY/ABSTRACT
Ambient air pollution exposure is a significant risk factor for the development and progression of
pulmonary disease. Short- and long-term exposure to air pollution constituents such as fine particulate matter
(PM2.5), nitrogen dioxide (NO2), black carbon (BC), and ozone (O3) has been associated with respiratory health
effects including negative impacts on lung function, increased incidence of respiratory infections, and
increased morbidity and mortality in patients with COPD. Individuals who live in communities with higher
proportions of historically marginalized populations and/or individuals with lower socioeconomic status (i.e.
“overburdened” or “Environmental Justice” [EJ] communities) have higher levels of air pollution exposure and
may be at increased risk of negative respiratory outcomes related to air pollution exposure. However,
disparities in exposures and their respiratory health effects in these vulnerable populations have been poorly
characterized. Additionally, there is a lack of adequate clinical tools to identify patients with higher burdens of
air pollution exposure and thus may be at increased risk of negative health effects.
The objective of this project is to characterize the relationship between combustion-related air pollution
exposure and respiratory health among vulnerable populations, including those who live in environmentally
overburdened communities, and to investigate clinically useful biomarkers of air pollution exposure in high-risk
individuals. The first aim of this proposal is to examine the effects of short-term exposure to air pollution,
including PM2.5, NO2, BC, and O3, on lung function in a large, nationwide cohort of adults, and to evaluate the
effects of neighborhood context and community-level factors (i.e. residence in an overburdened community) on
the relationship between air pollution exposure and pulmonary outcomes. The second and third aims of this
proposal focus on the assessment of novel biomarkers of air pollution exposure in a cohort of COPD patients
utilizing an innovative methodology, nasosorption, to collect nasal fluid samples from the upper respiratory
tract. Levels of inflammatory mediators and metals in these nasal fluid samples will be analyzed in order to
assess levels of these biomarkers in association with personal air pollution exposure, with the ultimate goal of
developing clinically useful tools for air pollution exposure assessment in high-risk patients.
This project will be conducted with the guidance of an expert team of environmental pulmonary
epidemiologists and physician-investigators. The principal investigator will partake in formal coursework in
epidemiology and biostatistics and will receive hands-on mentorship and training from leaders in the field of
environmental health and pulmonary medicine. The research will take place primarily at the Institute for Lung
Health at Beth Israel Deaconess Medical Center, with additional support and collaboration from the Harvard
School of Public and the Harvard Combined Pulmonary and Critical Care Fellowship Program.

Public health relevance
PROJECT NARRATIVE This project assesses the effects of short-term air pollution exposure on lung function in a large national cohort of adults with a specific focus on effects in vulnerable populations, and also evaluates the use of a novel exposure assessment technique, nasosorption, for the development of novel biomarkers of air pollution exposure in at-risk populations. The proposed project has valuable public health implications, both in characterizing the effects of air pollution exposure in high-risk individuals and developing novel clinical tools to identify patients who are highly exposed to air pollution, with the ultimate goal of informing policy and clinical practice to mitigate the effects of these exposures in vulnerable groups.